T32 Predoctoral Diversity Supplement for Victoria Behm

ABSTRACT
In 2022, the University of North Carolina at Chapel Hill was awarded a T32 competitive renewal grant,
responding to PA-20-142, to fund years 16-20 of the UNC Research Training Program in Complementary and
Integrative Healthcare (CIH). Our goal in this T32 Research Fellowship is to cultivate diverse, talented,
productive, well-trained, independent researchers at both the pre- and post-doctoral level as CIH research
leaders in investigating efficacy, effectiveness, mechanisms of action, and implementation of clinical integration
of complementary therapies and integrative health-care approaches. Our program highlights an
interdisciplinary array of research topics, methodologies and faculty mentors, providing rigorous training in
research methods to facilitate exploration of mind-body techniques and natural-product/nutritional therapies
and their applications in health promotion, chronic pain, metabolic syndrome, and other high-impact conditions,
with emphasis on enhancing access to CIH care in at-risk, underserved populations. The original proposed
Fellowship submission planned for five post-doctoral positions and two pre-doctoral positions; however, our
funded grant was reduced to five overall positions, with NIH/NCCIH providing the opportunity to apply for
supplemental funding for an exceptional individual who qualifies for the diversity supplement, to enhance NIH
goals for trainees from diverse backgrounds. This application, following NOT-AT-24-034, proposes the addition
of Victoria Yunez Behm, as a pre-doctoral fellow. Ms. Behm is a master’s trained Integrative Nutritionist who
continues to teach in the Nutrition and Herbal Medicine Program at the Maryland University of Integrative
Health. She is also a yoga teacher training instructor and recently completed a Master of Theological Studies
in Ethics at Duke University. Due to her deep commitment to extending multicomponent integrative health
interventions (including nutrition) to vulnerable communities, Ms. Behm is pursuing a PhD in nutrition under the
guidance of Dr. Alice Ammerman, a long-term mentor in the T32 program and a national leader in community-
engaged nutrition and lifestyle research. Her training will consist of T32 required courses (Responsible
Conduct of Research, Reproducibility and Rigor, Principles and Practices of Complementary and Alternative
Medicine, Mindfulness for Caring Professionals) and coursework within the Gillings School of Global Public
Health. In addition to coursework addressing her nutrition major, Ms. Behm plans to take courses designed to
develop her skills in qualitative research, quantitative methods, and community-engaged research. Her
mentoring team will include Dr. Ammerman and T-32 Directors Susan Gaylord and Dr. Keturah Faurot. Dr.
Gaylord will involve Ms. Behm in mind-body studies for underserved populations and Dr. Faurot will work with
Ms. Behm on designing nutrition interventions. Ms Behm will also benefit from participating with other T32
fellows in learning to address integrative health research challenges.

Public health relevance
PROJECT NARRATIVE This application utilizes the T32 Supplement Program to Promote Diversity in Health Research (NOT-AT-24- 034) to expand our long established, successful NIH T32 training grant that has provided rigorous training to pre- and post-doctoral fellows who have become skilled leaders in CIH research. In this supplementary application, we propose a three-year training program for Victoria Yunez Behm, a mater’s trained leader in integrative nutrition who has been accepted into UNC’s nutrition PhD program and is committed to extending multicomponent integrative health interventions to vulnerable communities. Ms. Behm will learn qualitative and quantitative methods and community engaged research as well as mind-body research methods for vulnerable populations, under the mentorship of Drs. Ammerman, Gaylord, and Faurot – all UNC faculty and T32 mentors.